Quantifying effects of comorbidities and genetics on cannabinoid exposure in the elderly

Project summary/abstract
Americans ≥65 years represent a growing segment of the US population who use cannabis for multiple ailments,
increasing about two-fold from 2015 to 2018. Despite these trends, knowledge about how the aging process
combined with comorbidities or genetic polymorphisms in drug metabolizing enzymes alter the safety of cannabis
remains limited. This knowledge gap is particularly worrisome given nearly all 50 states have passed some
legislation allowing legal medical cannabis use and that the elderly are more vulnerable to adverse drug events.
The non-psychoactive cannabidiol (CBD) and psychoactive ∆-9-tetrahydrocannabinol (THC) are the most
extensively studied cannabinoids in cannabis. CBD has been the top-selling herbal supplement ingredient in the
US natural channel since 2018. CBD received particular interest from the elderly suffering comorbidities who are
poorly managed with current treatments. CBD is eliminated from the body mainly by hepatic cytochrome P450
(CYP)-mediated metabolism (CYP2C19, CYP3A). Mean THC concentration in cannabis-related products was
reported to increase 2-fold from 2008 to 2017. THC is eliminated mainly by hepatic CYP-mediated metabolism,
primarily by CYP2C9, with a minor contribution by CYP3A. Biotransformation activity generally tends to slow with
age due to decreased blood flow and reduced liver mass. Both CYP2C19 and CYP2C9 harbor multiple reduced
function genetic variants that could further reduce the safety of CBD and THC. Therefore, the elderly with hepatic
impairment or carrying such genetic variants may be at heightened risk for adverse events from CBD and THC.
Collectively, there is an urgent and critical need to understand how comorbidities such as hepatic impairment,
along with select CYP variants, affect CBD and THC disposition in the elderly.
Because conducting clinical trials in the elderly can be challenging, model-based approaches such as
physiologically-based pharmacokinetic (PBPK) modeling and simulation can be used to project systemic
exposure to CBD and THC. The objective of this project is to incorporate age-related physiological changes,
hepatic impairment, and select CYP genetic variants, as well as oral or inhaled CBD- and THC-specific
characteristics, into novel PBPK models to predict CBD and THC disposition in hepatic-impaired elderly patients
(65-98 years) and assess the combined effects of age and genetic CYP polymorphisms on CBD and THC
exposure. We will (1) quantify the effects of age on oral and inhaled CBD and THC disposition and (2) develop
PBPK models to predict both oral and inhaled CBD and THC exposure in elderly patients with hepatic impairment
and (3) assess the impact of select CYP genetic variants on oral and inhaled CBD and THC exposure in the
elderly. Results from this project are expected to provide critical and timely data to inform consumers and health
care professionals about the safety linked to CBD and THC use among the elderly with and without hepatic
impairment or select CYP genetic variants. Importantly, results will lay the foundation for future benefit/risk
assessment of the complex natural cannabinoid mixture (cannabis/marijuana/hemp) in this special population.

Public health relevance
Project Narrative The proposed research project is relevant to public health because the elderly represents a growing segment of cannabis users in the US; however, health consequences from cannabis use in this special population are currently unclear. The proposed project is the first to quantify the impact of both age and hepatic impairment or select cytochrome P450 (CYP) genetic variants on cannabinoid disposition. Results are expected to inform consumers, medical professionals, and key stakeholders, including those working in the residential aged-care industry, about the exposure-risk/benefit relationship of cannabinoid use among the elderly, as well as those with hepatic impairment or select CYP genetic variants.